THIS PURCHASE ORDER INCLUDES SERVICES TO OBTAIN ANNUAL POPULATION ESTIMATES FOR STATE, COUNTIES AND CENSUS TRACTS BASED ON THE COUNTS PRODUCED BY THE US CENSUS BUREAU. THESE SPECIFICALLY-DEVELOPED EST

THIS PURCHASE ORDER INCLUDES SERVICES TO OBTAIN ANNUAL POPULATION ESTIMATES FOR STATE, COUNTIES AND CENSUS TRACTS BASED ON THE COUNTS PRODUCED BY THE US CENSUS BUREAU.SPECIFICALLY-DEVELOPED ESTIMATES